Phasic dopamine and symptom domains of mental illness

Project Summary
Activity patterns in the brain establish how information is perceived and processed. Disruptions of these patterns
are likely a major contributor to the pathophysiological basis of mental disorders. Neurons in the ventral midbrain
system play an essential role in learning and motivation and mutations within several genes known to regulate
action potential firing patterns have been identified in psychiatric disorders, yet virtually nothing is known of the
impact of these mutations on neuronal physiology, circuit function, and social behavior. We have demonstrated
that inactivation of different ion channels associated with the pathophysiological basis of mental disorders can
have differential effects on neuronal physiology and phenotypic outcomes. Neurons of the ventral midbrain
express a suite of channels that regulate the action potential waveform and activity patterns. Based on these
diverse functions, we propose that elucidating the physiological and phenotypic outcomes associate with a gain
or loss of function of these proteins will provide important insight into how their disruption yields a mosaic of
behavioral phenotypes. To this end, we have developed a viral vector-based systems for rapid mutagenesis and
expression of pathogenic mutations in midbrain cells and demonstrated that altered function of different channels
yields both overlapping and non-overlapping behavioral phenotypes in mice. The experiments proposed here
will further elucidate common and uncommon phenotypic outcomes and the impact of specific mutations on the
operation of distinct dopamine subsystems.

Public health relevance
Project Narrative Discrete neuronal activity patterns define how information is processed in the brain. The manner in which disruption of these patterns by disease-associated mutations impacts behavioral regulation is poorly understood, but likely contributes to the etiology of many symptom domains of mental illness. We will use advanced genetic techniques coupled with in vivo imaging and ex vivo electrophysiology and behavior to establish how distinct potassium channels implicated in neurodevelopmental disorders impact dopamine neuron physiology and function.